Enabling Infectious Disease Research Capacity in the Peruvian Amazon

PROJECT SUMMARY
Peru is rapidly increasing in stature in public health research, and many successful Peruvian-US research
teams have expanded research capacity through training grants based in major universities in Lima. Many of
these partnerships have satellite activities to study infectious diseases in Iquitos, the major city in the Peruvian
Amazon, but these research and capacity building activities have largely bypassed academic institutions in
Iquitos. This D43 training grant is specifically designed to address and correct this disparity, offering a
collaborative research training program in partnership with the Universidad Nacional de la Amazonia Peruana
(UNAP; National University of the Peruvian Amazon), the largest health education institution in the region. In
this renewal, our goal is to continue expanding the local workforce of highly trained professionals with public
health and infectious diseases research skills, which we propose to achieve by continuing the training of three
current trainees on towards the Doctoral Program in Public Health at UNAP and receive two incoming
specialist physicians trainees to complete a master’s degree in public health at UNAP. This intensive,
mentored training program with both north-south and south-south training components will be led by faculty
from four collaborating institutions (UNAP, University of Virginia, Universidad Peruana Cayetano Heredia [the
leading biomedical research university in Peru, located in Lima], Tulane University, and the University of
Arizona (UA)). The majority of the training will be conducted locally at UNAP through training modules and
online components. We will supplement the two-year MPH program at UNAP with complementary, short-term
training modules led by UVA, Tulane, UPCH, UA and USDA faculty that will be open to all MPH and doctoral
students in the UNAP program, expanding the impact of the training program to approximately 80 additional
master’s level trainees and 10 doctoral level trainees. Modules will be specifically focused on human subjects
training, rigor and reproducibility of research, scientific writing and grant writing, data management and
visualization, scientific communication and regulatory aspects of research in Peru and the US. Working closely
with UNAP faculty, we will integrate new program content into the existing MPH and Doctoral curriculum,
providing sustainable, ongoing benefits for future UNAP MPH and Doctoral classes. MPH and Doctoral
trainees will conclude their training by taking a leading role in writing and assembling a Fogarty International
Center Global Health Fellowship, while additionally, Doctoral level students will pursue a Prociencia Seed
Grant [entity of the Peruvian Counsel on Science, Technology, and Technological Innovation], the premier
scientific funding agency in Peru) under the direction of a mentoring team. We will continue to offer one-month
short courses during Years 2-5 for training community field workers and laboratory support staff will also be
offered, expanding the pool of research program support staff in Iquitos.

Public health relevance
NARRATIVE Peru is a global center of training in public health and research in tropical medicine and the study of emerging diseases, but training and leadership is exclusively concentrated in the capital city of Lima and access to the training has largely bypassed academic institutions and professionals in Loreto, the largest department in the Peruvian Amazon. This D43 grant renewal seeks to continue to build research capacity to correct this disparity in opportunity by offering a collaborative research training program in partnership with the Universidad Nacional de La Amazonia Peruana (UNAP) complemented by skills training and research mentorship provided by the University of Virginia, Tulane University, and Universidad Peruana Cayetano Heredia. The goal of this training program is to train health researchers capable of leading research to diminish the burden of endemic and emerging infectious diseases in one of the highest burden areas for tropical and neglected diseases in the Americas.